IGF::CL::IGF: This service is for Meeting planning and administration for the American neurological association (ANA) meeting

This service is for Meeting planning and administration for the American neurological association (ANA) meeting